SEROTONERGIC SCREENING TEST IN DEPRESSION AND ITS IMPLICATION FOR TREATMENT

To develop a meaningful screening test for depressed patients to predict whether a patient will respond to serotonin reuptake inhibitor antidepressant medication.